Powering the Brain: the Cell Biology of Neuroenergetics

Project Summary
Synapses are conserved structures that govern information flow through neural circuits. My laboratory is
interested in understanding how synapses are assembled and maintained in vivo to build the circuits that
underlie behavior, and how they are modified to store memories. We recently made an unexpected discovery
that is orthogonal to our research program and reframes our understanding of the principles governing synaptic
function. We discovered that during energy stress, glycolytic proteins in C. elegans dynamically relocalize to
synapses to meet local energy demands and power the synaptic vesicle cycle. Our findings underscore an
important relationship between individual synapses and their local energy environments. Based on these
findings we propose the bold hypothesis that local regulation of energy metabolism underlies the plastic
properties of specific neurons and synapses, thereby governing circuit function and animal behavior.
Our proposed hypothesis is unconventional. While functional magnetic resonance spectroscopy studies
have demonstrated that brain metabolism is tightly linked to neuronal function at a circuit level, how energy
metabolism is regulated at a subcellular level is not understood, or considered in the context of synaptic
physiology and plasticity. Could energy metabolism be compartmentalized within cells to preferentially power
specific cellular functions? Could local regulation of energy flow within neurons (neuroenergetics) restrict, or
potentiate, information processing and circuit function? Understanding how neuroenergetics is locally regulated
within neurons could be paradigm shifting, reframing our knowledge regarding the mechanisms that regulate
synaptic function, both in physiology and in disease.
In this Pioneer proposal, we rigorously examine our hypothesis with new cell biological probes to be used
in vivo, in specific neurons and in behaving C. elegans to understand neuroenergetics in single synapses. We
examine how membrane-less metabolic subcompartments form through liquid-phase transition, and the
physiological implications of their localization to subcellular regions. Completion of the proposed work could
have impact beyond the field of neuroscience, as it could broadly reframe the importance of local metabolism
and its functional role in meeting local energy demands in cells.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will result in a deeper understanding of the molecular mechanisms underlying synaptic physiology in the neural circuits of living organisms. Synaptic physiology influences the functional output of the nervous system, behaviors. Here we propose to examine the bold hypothesis that local energy production underlies synaptic function, a hypothesis that if true could reframe the way we think about how synaptic function is regulated in vivo and how it could go awry in disease.